Developing a Tailored, Theoretically-Driven Smartphone Physical Activity Intervention for African American Women

PROJECT SUMMARY/ABSTRACT
Candidate. The Mentored Patient-Oriented Research Career Development Award (K23) will enable me to
acquire the focused training necessary to become an independent and leading investigator in technology-
based physical activity interventions among African American women and reduce their risks for many chronic
diseases. To date, I have gained exceptional training experiences in behavior change theories, research
methods, multiculturalism, and diversity across different adult populations. This foundation facilitates the next
steps of my proposed training, namely, developing expertise on the central factors related to regular physical
activity engagement among African American (AA) women, and the skills necessary for the development,
implementation, and evaluation of smartphone app technology prevention and intervention research. The
proposed training and research will prepare me to take a leadership role in technology-enhanced interventions
targeting PA disparities.
Proposed Research. Only 36% of African American (AA) women meet the national recommendation of
150 minutes per week of moderate-to-vigorous physical activity. Consequently, this group is disproportionally
impacted by many associated disease conditions, including type 2 diabetes and cardiovascular disease.
Research on physical activity disparity in this group indicates a triadic and reciprocal interaction between
individual characteristics, social norms, and environmental factors. Smartphone application technology (e.g.
apps) has been recommended as an innovative and low-burden platform to enhance theoretically driven
approaches to promoting PA among AA women. This technology facilitates the development of effective, and
scalable approaches delivered in real time and that can reach people in their daily environments. Moreover,
this platform supports the development of innovative social networks for social support. Further, a counseling
session intervention that helps AA women to develop an initial, individualized plan for PA before starting a PA
program may help to increase levels of motivation for physical activity. This K-award applicant proposes an
individually tailored, culturally relevant and smartphone delivered PA program including short text messages
adapted from an effective internet-delivered intervention. The app program will contain activity monitoring
features, educational videos, information on alternative and nearby environments, and a peer-to-peer chatroom
to increase social support for PA behaviors in AA women compared to general wellness text messaging control
condition.

Public health relevance
PROJECT NARRATIVE African American (AA) women are overwhelmingly physically inactive and suffer disproportionately from associated health conditions, including type II diabetes, coronary heart disease, and obesity. Smartphone applications technology provides a substantial opportunity to deliver evidenced-based behavioral interventions tailored for AA women and help to promote adherence to physical activity.